Automated Virtual Follow-up to Reduce Premature Treatment Discontinuation

Eariy dropout from depression treatment is, unfortunately, the norm. Interventions to reduce dropout from depression treatment have been repeatedly shown to improve clinical outcomes. The common ingredient of all of these collaborative care or care management programs is systematic outreach to assess outcomes and improve adherence. Furthermore, previous research conducted by our group indicates that eariy dropout from depression treatment is heterogeneous - and a substantial minority of those discontinuing treatment eariy experience good outcomes. These data suggest that more targeted dropout-reduction interventions (targeting only those in need of additional treatment) could reduce costs - and facilitate implementation - of outreach to improve adherence. Recent developments in health informatics have created to potential for more efficient and more targeted outreach programs to address dropout from depression treatment. First, electronic medical records databases allow real-time evaluation of patients who are

Public health relevance
Early dropout from depression treatment remains a major public health concern. Addressing this quality gap will require outreach programs that are both affordable and scalable. This pilot project will implement and evaluate a fully automated program (based in health systems' electronic medical records) for detection of eariy dropout and population-based outreach to promote re-engatement in treatment.